BLRD Research Career Scientist Award Application

Amyotrophic lateral sclerosis (ALS) is a poorly understood neurodegenerative disease characterized
predominantly by motor neuron death with no effective treatment to date. ALS has been designated as a service
connected disease by VA since Veterans are at a higher risk of contracting this devastating and fatal disease.
The PI of this Research Career Scientist (RCS) application, Dr. Haining Zhu, has been working on ALS for 20
years since he started his independent academic career. The long-term goal of his research program is to
determine the molecular mechanisms of ALS disease pathogenesis and progression. Empowered by better
mechanistic understandings, his laboratory is also engaged in translational research to discover novel
therapeutic targets and to identify compounds for drug development. The success of his research program will
benefit the healthcare of veterans, particularly those afflicted with ALS.
Dr. Zhu's VA-funded Merit project is to study the RNA binding protein Fused in Sarcoma (FUS), which
has been implicated in both familial and sporadic ALS. Familial ALS represents approximately 10-15% of all
cases and ALS genes provide much-needed “molecular handles” for studying mechanisms that might be
relevant to all ALS cases. His laboratory has been working on the function of FUS protein under physiological
and pathological conditions. His laboratory has made several novel findings, including the identification of the
nuclear localization sequence (NLS) in FUS (Gal, 2011), the determination of the crystal structure of FUS NLS
in complex with the nuclear transport receptor transportin 1 (Niu, 2012), and the characterization of one of the
first Drosophila models (Xia, 2012). Two of his studies were published in PNAS in 2014 and 2018, respectively.
His laboratory demonstrated that liquid-liquid phase separation (LLPS) of the FUS protein played a critical role
in chromatin binding and transcription regulation (Yang, 2014). His laboratory also found that FUS-positive
granules contained proteins involved in protein translation and nonsense-mediated decay (NMD) of RNA.
Moreover, mutant FUS suppressed protein translation and hyper-activated NMD (Kamelgarn, 2018). This work
was considered so significant that PNAS published an accompanying Commentary.
In the current funding period (renewed in 2020 until 2024), the overarching hypothesis is that the
dysregulation of protein translation and RNA nonsense-mediated decay (NMD) contributes to FUS toxicity and
motor neuron dysfunction. His laboratory proposed to determine (1) what properties of mutant FUS drive the
dysregulation of protein translation and NMD; (2) whether mRNA decay and protein translation are impacted
by mutant FUS with any specificity; and (3) whether corrections of these defects restore the balance between
protein translation and NMD.
During the proposed RCS period, Dr. Zhu plans to expand his research program by focusing on three
directions. The first is to use the unique unaffected mutation carriers in the familial ALS cohort to identify
resilience factors. The second is to use patient-derived iPSC lines for translational research and therapeutic
development. The third is to identify and optimize better compounds to promote PTC readthrough as a
potential therapy for a related neurodegenerative disease, frontotemporal dementia (FTD).
After relocating to Tucson, AZ in July 2021, Dr. Zhu has actively engaged in several functions and
collaborations at Southern Arizona VA Healthcare System (SAVAHCS). Dr. Zhu started to serve as the site PI
of VA Biorepository Brain Bank (BBB), which is the sole ALS biorepository in the entire VA system. This joint
operation with the Boston VA provides a critical resource for the entire ALS research community. In addition to
leading a productive research program, he serves on VA committees at the local and national levels. He
collaborates with many VA and non-VA scientists. The support from the RCS program will enable Dr. Zhu to
make continuous progress in ALS research and to benefit the healthcare of veterans.

Public health relevance
Amyotrophic lateral sclerosis (ALS) is a neurodegenerative disease and currently there is no cure. Veterans are at a higher risk of being affected with the disorder, thus ALS has been listed as a disease entitled to presumptive service connection. The PI’s Merit project is to use well-defined genetic models to determine the mechanisms by which mutations in the RNA binding protein FUS disrupt protein biosynthesis and RNA metabolism and induce downstream toxicity and neuronal death. The results from his project will not only provide critical insights into the pathophysiology of ALS but will also identify novel targets for therapeutic developments. Since the relocation to Tucson, the PI has taken new responsibilities as the site PI of the nationwide VA Biorepository Brain Bank (BBB). As the only ALS biorepository for veterans across the U.S., VA BBB is a critical resource for the entire ALS research community. The support from the Research Career Scientist program will enable the PI to make continuous contributions to the healthcare of veterans, particularly those afflicted with ALS.